Proteasome Targeting for Alloreactive Plasma Cells

Abstract
The induction of plasma cells that secrete antibodies against donor tissue alloantigens is
a major barrier to successful transplantation. Moreover, because many plasma cells are
remarkably long-lived, the resulting antibody titers are exceptionally durable. Hence
strategies are needed to eliminate long-lived plasma cells that generate allospecific
antibodies. A current dominant strategy for depleting plasma cells centers on
compounds that interfere with the proteasome. Plasma cells are thought to uniquely
require proteasome function to survive. However, for reasons unclear, substantial
numbers of allospecific plasma cells resist the action of available proteasome inhibitors
(PIs). This project centers on the central hypothesis that mature long-lived plasma cells
(LLPCs) are especially resistant to PI-induced cell death. Our experiments test this idea
while also working towards defining how the proteasome interfaces with regulators within
the endoplasmic reticulum such as the chaperone protein BiP and other cytosolic
regulators of proteostasis including the autophagy regulator p62 and VCP/p97, an
ATPase that controls movement of proteins from the ER into the cytosol. Specifically, we
will: 1) Define the role of BiP in controlling PI sensitivity in LLPCs, 2) Define the key
regulators of ER-to-cytosol protein trafficking/disposal and their role in controlling PI
sensitivity in LLPCs, and 3) Identify the gene regulatory networks underlying LLPC
resistance to PIs.
.

Public health relevance
Project Narrative We will evaluate the mechanisms whereby antibody-producing plasma cells succumb to or develop resistance to drugs that inhibit proteasome function. Our results should reveal novel strategies to deplete problematic plasma cells, and hence improve outcomes in transplantation and autoimmunity.